HEREDITARY LUNG DISEASE

Cystic fibrosis (CF) and alphal-antitrypsin (alphalAT) deficiency are the two most common lethal hereditary disorders in the USA and Europe. The major clinical manifestations of both are in the lung. CF results from mutations of the Cystic fibrosis transmembrane conductance regulator(CFTR) gene, a 27 exon gene occupying 250 kb of chromosome 7. All organs with exocrine glands are affected, but the major clinical manifestations are in the lung, with impacted mucus, clinic infection, inflammation, and airway and parenchyma derangements. Studies over the past year have centered on understanding the control of expression of the CFTR gene and devising strategies to clear the lung of purulent mucus and protecting the respiratory epithelium from the chronic neutrophil dominated inflammation that characterizes the disease. alphalAT deficiency results from mutations in the alphalAT gene, a 7 exon gene occupying 12 kb of chromosome 14 causing a systemic deficiency of alphalAT, the major inhibitor of destructive proteolytic enzyme, neutrophil elastase. In the context of the deficiency of alphalAT, neutrophil elastase released by neutrophils in the lung goes uninhibited, resulting in progressive destruction of the lung and eventual emphysema. Recent studies have concentrated on the mechanisms of attraction of neutrophils, and enhanced neutrophil elastase to the lung in this disorder. For both cystic fibrosis and alphalAT deficiency major emphasis is being placed on gene a (see project ZOI HL 02536-01 PB).